High-throughput sequencing of the T cell receptor in colorectal tumor infilt

PROJECT SUMMARY/ABSTRACT Colorectal cancers (CRC) are the second leading cause of cancer mortality in the United States. Management of CRC patients includes the need to accurately ascertain patient prognosis and to detect progression following therapy. We hypothesize that Tumor Infiltrating Lymphocyte (TIL) count and clonality will be able to more accurately predict patient outcome than currently existing approaches that are based on using disease stage only. We also hypothesize that measuring the TIL clones in T cells derived from blood following therapy will provide a method to accurately predict progression of CRC. Our hypothesis is supported by growing evidence that the presence of intraepithelial Tumor Infiltrating Lymphocytes (TILs) is strongly related to patient outcome in CRCs and many other diseases. Our opportunity to succeed is based on new technologies developed by our team. While current technologies for assessing TILs are not appropriate for use in a clinical setting, we will use new technologies developed by our team that can reproducibly and quantitatively measure the overall number and clonality of TILs in a specific sample. The assay Immunoseq quantifies rearranged T-cell receptor β CDR3 chains. We will combine these measures with additional factors to derive a prognostic metric that can be practically used in a clinical setting. To derive our metric we will measure colon cancer biopsy sections and matched blood samples collected at two time points (baseline and 6 months) from 80 stage II and III colon cancer patients with at least two years of clinical follow-up.

Public health relevance
PROJECT NARRATIVE An accurate prognosis assists both colorectal cancer patients and clinicians to develop a personalized treatment plan. The quantity and clonality of Tumor Infiltrating Lymphocytes (TILs) are independent and informative prognostic factors for colorectal cancer. However, the current methods to quantify TILs are not conducive to the clinical setting. We propose to develop a new colorectal cancer prognostic metric, and to develop a method to detect tumor progression, both based on quantitative and reproducible measures of TILs in tumor samples and in blood. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Colorectal cancers (CRC) are the second leading cause of cancer mortality in the United States. Although screening and improved treatment options have improved survival rates, the set of currently utilized prognostic factors are inadequate to segregate many CRC patients into appropriate treatment decisions, particularly for those patients deemed to have stage II and III tumors. For most stage II patients there is minimal difference in the five-year survival rates for those who do versus those who do not receive adjuvant chemotherapy. However higher 5-year survival rates for with stage IIIA compared to stage IIB. In addition CRC outcomes vary widely between patients with the same disease classification, disease relapse occurs in 20-30% of patients with localized cancer(2). These observations suggest that the traditional prognostic factors (e.g., disease stage) lacks sufficient granularity to adequately predict patient outcome(1). Evidence is mounting that the presence of intraepithelial Tumor Infiltrating Lymphocytes (TILs) in CRC tumors, as with other epithelial tumors, is an independent and highly informative prognostic factor. The current technology for assessing TIL is not highly quantitative, and is subjective - counts of total TIL and T cell subtypes in a single cross-section based on immunohistochemistry (IHC). Our goal is to develop a new set of prognostic factors based on quantitative measures of CRC TIL -- including quantity and T cell receptor (TCR) sequence distribution (a.k.a., clonality). This technology will not only provide a more accurate measurement of TIL count in a sample, but it will also provide a measure of T cell clonality, which cannot be assessed with IHC. A primary hallmark of a tumor specific immune response is a large oligoclonal expansion of T cells within a tumor, which IHC cannot assess. We propose to test two hypotheses regarding the use of TIL TCRs in clinical management of CRC patients. First (Aim 1) we hypothesize that the use of TCR number and clonality (a two dimensional quantitative measurement) in CRC tumors can be used to more accurately predict patient prognosis than stage alone. Moreover, because the set of T cell clones we identify in Aim 1 are highly enriched for tumor specific T cell response, we will test the hypothesis (Aim 2) that the expansion these T cell sequences in the blood helps predict recurrence. T cell sequences are nearly unique, so they can be used to track the same clones in different tissues and over time. A product of testing these hypotheses will be quantitative metrics that are strongly associated with prognosis (Aim 1) and time until recurrence risk (Aim 2). We will develop our metrics by measuring the TCR repertoire in TIL from 80 colon cancer biopsy samples and in T cells derived from matched blood samples collected at two time points (baseline and 6 months). All patients will have a minimum of two years of clinical follow up and vital status. The samples are derived retrospectively from a study for colon cancer (the ColoCare repository) led by members of our team. The specific aims of the grant are: 1. To test the hypothesis that TCR number and clonality predict recurrence free survival in colon cancer patients who presently have similar prognosis. We will measure the TCR repertoire in colon tumors from 80 patients with colon cancer, 40 cases with stage II and 40 cases with stage III. In this study, all stage II patients are treated with surgery alone and all stage II patients are treated with surgery followed by the same dose regiment of FOLFOX. We then stratify on stage and predict recurrence-free survival from the quantity and clonality of the infiltrating T cells, calculated using approaches we developed, as well as tumor histology, node involvement, metastasis (TNM), age, and sex to determine the prognostic value of the quantitative TCR measurements above and beyond these more traditional measurements. 2. To test the hypothesis that the expansion in blood of TCR sequences identified in Aim 1 at six months can predict recurrence. We use the colon tumor TIL sequences to identify the tumor specific T cell clones. We sequence the T cells in blood at baseline and six months post-surgery. The tumor specific sequences are identified and tracked in blood using the nearly unique TCR sequencing as molecular markers. We then calculate the rate of expansion of those clones in the blood of patients at 6 months, and use the expansion rate as a predictor of recurrence-free survival (post 6 months). The products of our research will include putative metrics that can be further tested (and refined) in follow- up studies using large sample sets.